Admin Core

ABSTRACT
The overarching objective of the Administrative Section is to facilitate and manage the successful
interdisciplinary team science required to move kidney MPS platforms through to regulatory
qualification as drug development tools (DDT). This will be accomplished by fostering communication,
collaboration, integration and coordination among the components of the Translational Center including
Project Staff, the Internal Executive Committee, the External Advisory Committee, and the MPS Resources
and MPS Qualification Sections. The Administrative Section will also manage communication with NIH, FDA,
and industry partners to achieve these goals. This will require a high level of scientific expertise, and a
corresponding focus on scientific rigor and data reproducibility in order to allow DDTs to support specific
kidney disease related context of use cases. As a key component of this translational center, the
Administrative Section will have primary responsibility for coordinating the operations, establishing necessary
working groups and relationships with external partnerships. The Administrative Section will additionally
provide project management, budgeting, and fiscal management for all Translational Center activities. The
Administrative Section will be responsible for overall day-to-day center operations, research, and community
outreach activities, including information dissemination and data sharing with the Microphysiological Systems
Database (BioSystics). The Administrative Section, in conjunction with the Center’s directors and
committees, will continually monitor all Center activities and plans that are integral to the functioning of the
Center through the following Specific Aims: (1) To support core functions of the Translational Center; (2)
To establish, organize, and support scientists, collaborating investigators and staff, in developing and refining
study protocols, manuals, and standard operating procedures. (3) To handle Center communications,
including engaging kidney disease patient organizations, professional organizations, clinicians, and
scientists, for dissemination of data and results. (4) To have ultimate responsibility for conducting all fiscal
matters pertaining to the Center, including preparing annual fiscal reports to the NIH. (5) To provide expertise
in statistics, bioinformatics and data sharing for the Center.
The Administrative Section is led by a team of highly experienced scientists and physicians, each with well
supported NIH research programs. The leadership team has extensive experience in leading and
participating in clinical and translational research projects at multiple institutions, including involvement in
multiple NIH Consortia. The assembled management team is also highly experienced in managing the
complex budgeting, operational and personnel issues that arise from running a research program with
multiple scientific partnerships.